Injury Control Digital Innovation Core

PROJECT SUMMARY (Injury Control Digital Innovation Core) While systematic public health approaches successfully reduced incidence and mortality of several types of injury over the last century, these gains have been largely erased in the last decade due to new risk factors and reductions in old protective factors. A novel, rigorous approach to injury control is needed. Recent evidence, both from our team and researchers beyond our state, suggest that the use of novel “digital health” tools can be feasible, acceptable, and efficacious in measuring and reducing the incidence and the consequences of injuries. Promising preliminary data exists regarding the utility of digital health for all aspects of injury control, ranging from surveillance to tertiary prevention. The development and dissemination of effective injury-focused digital products are limited, however, by lack of rigor and expertise in their development, evaluation, and dissemination. In the Injury Control Digital Innovation Core, we will be able to extend our prior work to help transform the measurement and delivery of injury control on a wider scale by providing expert support and technical assistance to junior investigators and COBRE affiliated researchers at Rhode Island Hospital. The long-term goal of Injury Control Digital Innovation Core is to establish a regional and national hub leading the development, analysis, and dissemination of high-quality, scientifically sound, effective digital health innovations focused on injury control. This objective will be met through the following aims: 1) Provide a scientifically rigorous structure that facilitates the development and evaluation of innovative digital health-based injury control, through expert consultation on qualitative research (user experience testing, formative research), analysis of big data, and study design; 2) Facilitate partnerships between researchers, clinicians, patients, and relevant industry-based partners, with a focus on enhancing quality and dissemination of COBRE-funded injury control research and 3) Develop and maintain ongoing an “innovation lab” of asynchronous and real-time injury-focused digital health training resources for junior researchers. The achievement of these aims in the Injury Control Digital Innovation Core of the Injury Control COBRE will have immense impact on the capabilities and impact of our local researchers. It will also enhance the scientific rigor of the field at large by disseminating best practices and innovative new scientific modalities for injury control. Finally, we will be able to grow the long-term public health impact of our COBRE-affiliated researchers, by enabling them to use measurement and intervention tools that represent the future of rigorous science.